Coaching and Leadership in Autism Support Settings (CLASS)

PROJECT SUMMARY
The purpose of this study is to test the clinical effectiveness of the Research Units on Behavioral
Interventions in Educational Settings (RUBIES) program relative to educator psychoeducation on externalizing
behaviors of autistic children in public elementary schools as well as the effects of an organizational
implementation strategy, Helping Educational Leaders Mobilize Evidence (HELM), versus an implementation
attention control on RUBIES sustainment. The increased prevalence of autism spectrum disorder (1 in 36
children) in the United States along with the exorbitant cost of care of supporting one autistic individual with
and without intellectual disability across their lifespan ($2.4 and $1.4 million, respectively) creates a sense of
urgency to improve outcomes for autistic children. Publicly funded education systems are the primary setting in
which autistic children receive services; however, behavior management strategies that educators can use for
this population often are extremely time-consuming and resource-intensive. Schools carry unique service
delivery opportunities and constraints that necessitate careful evaluation of programs and practices in that
context. There is a dire need to support schools to build systems and structures to support implementation with
fidelity and sustainment over time. To address this, we propose a cluster-randomized, hybrid type 2
effectiveness-implementation trial with schools randomized to: 1) educator coaching in RUBIES and school
participation in HELM; 2) educator coaching in RUBIES and school participation in an implementation attention
control (IAC) condition; or 3) a control arm incorporating an active clinical comparator, educator
psychoeducation. We will enroll 40 schools, 120 educators, and 120 autistic children. We aim to: 1) test the
clinical effectiveness of RUBIES, relative to educator psychoeducation, on externalizing behavior of autistic
children in public schools; 2) test the effects of an organizational implementation strategy (HELM) versus
implementation attention control (IAC) on RUBIES sustainment; and 3) evaluate the mechanisms of RUBIES
and HELM on child and implementation outcomes. The proposed work directly responds to high priority
research areas of the US Department of Health and Human Services Interagency Autism Coordinating
Committee’s Strategic Plan for Autism Research, which calls for expanded research on the translation of
proven-efficacious interventions into the community, NIMH Strategic Priority 3.3 to test interventions for
effectiveness in community practice settings, and NIMH Strategic Priority 4.2 to expedite adoption, sustained
implementation, and continuous improvement of evidence-based mental health services. If successful, this
study will have substantial public health impact because it will produce an effective intervention for a prevalent
problem among a high impact population in schools across the USA and will determine how to sustain this
(and other) intervention(s) with high fidelity, to the betterment of health.

Public health relevance
PROJECT NARRATIVE Many school-based behavioral health interventions for autistic children are ineffective, for two primary reasons: 1) targeted reduction of externalizing behaviors in autistic children requires context-specific assessment and intervention on functional causes, but there are no widely-accessible, empirically-supported, manualized interventions that efficiently train educators to do this; and 2) despite the known importance of intervention fidelity for achieving positive clinical outcomes, deficits in malleable organization-level factors, including leadership, implementation context, and operating policies and procedures, frequently stymie efforts to implement autism interventions with fidelity and sustain them over time. This study will evaluate the effectiveness of the Research Units on Behavioral Interventions in Educational Settings (RUBIES) program vs. educator psychoeducation for autistic children in public elementary schools and also test an organizational implementation strategy, Helping Educational Leaders Mobilize Evidence (HELM) to support sustained, high- fidelity delivery of an evidence-based practice for autistic children with co-occurring externalizing behaviors. The proposed study’s collaboration with publicly funded educational systems has the potential to impact service delivery and make educational supports readily accessible to the public, optimizing outcomes and reducing the need for ancillary services, thereby lowering cost of care.